Multidisciplinary Cardiovascular Research Training

ABSTRACT
Despite modern advances in diagnsotics and therapeutics, more individuals die of cardiovascular disease
across the globe than from any other disease. This is longstanding training grant dedicated to preparing the
next generation of academicians for careers in cardiovascular disease research. The Program consists of eight
educational opportunity pods covering a range of topic areas from clinical / population science to basic and
translational research. These Pods focus on research opportunities in vascular disease (including thrombosis
and inflammation), metabolism, genetics, stroke, cardiac myocyte biology and arrhythmia, women's heart
disease, and aging. These latter two pods represent new and expanded training opportunities leverage major
new institutional programs. The grant provides both didactic training as well as research immersion for MD, MD
PhD, or PhD trainees. This grant, now in its 20th year, has trained a large number of investigators, many of
whom have led paradigm changing and sustained research programs and have trainees of their own. Many of
the recent trainees have obtained NIH K or even R level funding, with academic positions. The core leadership
team consists of three senior faculty, each with a substantial portfolio of training experience, who are drawn
from the fields of vascular biology, cardiovascular disease, and cardiovascular pharmacology. The program is
integrated with common didactic coursework in instruction of responsible conduct of research, a skies of
cutting edge scientific seminars, and an interactive networking program that facilitates interchange among
trainee peers and mentors. The overall goal has been and will be to create and sustain the next generation of
cardiovascular scientists to focus on the most important disease of our era.

Public health relevance
PROJECT NARRATIVE Quite recently, the steady decades-long decline in cardiovascular disease mortality has begun to reverse course, creating the public health imperative to better understand the causes and treatments for cardiovascular disease. Building on an exceptionally strong prior track record of academic training in cardiovascular research, this renewal proposal seeks to train the next generation of investigators with modern techniques and tools for cardiovascular research, including in new areas particularly relevant to the aging demographics of the American population. Working with a strong cohort of experienced faculty, a diverse pool of trainees will immerse themselves in both experiential/project-based learning as well as didactic training in critical elements of cardiovascular science. This program will help mold future thought leaders to create sustainable advances in our efforts to prevent and to treat a broad spectrum of cardiovascular diseases.